Mechanisms underlying impaired hippocampal physiology in Fragile X Syndrome

PROJECT SUMMARY
Fragile X Syndrome (FXS) is a neurodevelopmental disorder that can cause impaired spatial memory and
atypical spatial behaviors such as “elopement,” or wandering around and becoming lost. Current treatments for
FXS are limited and do not treat underlying neurological changes that may be associated with these symptoms.
Activity in the CA1 subregion of the hippocampus supports spatial memory and spatial cognition, making it an
important candidate to study in the context of FXS; however, research into whether differences in
neurophysiological activity in CA1 in FXS contribute to impaired spatial behaviors and memory is lacking. The
goal of this project is to examine whether the activity in CA1 that supports spatial memory formation is impaired
in a rat model of FXS. The studies will use in vivo electrophysiology to record the activity of spatially modulated
CA1 neurons after introduction to a novel environment as a model of spatial memory formation in a rat model of
FXS (Fmr1 knockout, hereafter “FXS rats”) and wildtype (WT) control rats. Specific Aim 1 will test whether the
modulation of individual neurons by the extracellular 6-10 Hz theta rhythm is normal in FXS rats. This Aim will
assess whether this modulation is present from the onset of exposure to a novel environment in FXS rats as it
is in WT rats. Specific Aim 2 will test whether coding of spatial paths by coordinated ensembles of spatially
modulated CA1 neurons, which develops with experience in novel environments in WT rats, fails to develop at
the same rate in FXS rats. Specific Aim 3 will examine the reactivation of previously active CA1 neuron
ensembles during waking rest and sleep in FXS and WT rats. This Aim will test the hypothesis that CA1 neuronal
ensembles representing novel environments are not preferentially reactivated during rest and sleep in FXS rats
in contrast to results from WT rats. The results from these proposed experiments may reveal specific impairments
in hippocampal mechanisms that support spatial memory in FXS and may suggest novel treatment targets for
FXS.
This fellowship will allow me to develop the necessary technical and professional skills to pursue a career as a
principal investigator performing independent research. I believe my choice of institution and sponsor is ideal for
completing my proposed project as well as the training necessary to pursue my long-term career goals. The
Institute for Neuroscience at UT Austin offers a rigorous PhD program, a collaborative work environment where
I am regularly able to present my work and receive feedback, and opportunities to teach and mentor students.
Through the college’s career services for graduate students, I am also able to attend courses in subjects such
as science communication, data management, and planning rigorous and reproducible science, as well as to
meet individually with a career counselor. Through this fellowship, I will develop the skills necessary to continue
onto future academic positions and continue to research network impairments in cognitive disorders.

Public health relevance
PROJECT NARRATIVE. Fragile X Syndrome (FXS) is a neurodevelopmental disorder that is associated with deficits in spatial memory, but a neurological mechanism underlying these impairments has not been identified. This project aims to identify specific neurophysiological impairments in the CA1 region of the hippocampus, which is important for spatial memory and navigation, after introduction to a novel environment in a rat model of FXS. By doing so, this project may provide novel treatment targets that can specifically address deficits in spatial memory in FXS.